U-RISE Training the Next Generation of Basic Biomedical Researchers A Holistic Approach

Project Summary/Abstract. We seek to establish the Undergraduate Research Initiative for Student
Enhancement (U-RISE) program at California State University, Northridge (CSUN). We use a growth
mindset as a scaffolding for the activities and interventions we propose in this new program. The future of
our nation needs scientific expertise to maintain our current global status and to help overcome the
significant issues that confront humanity. This requires that this nation develops and trains the people who
can solve problems facing us such as new and emergent disease such as Covid-19, including nutrition,
water safety, plant productivity, normal vs. abnormal cellular processes, and mental health. However, not
all sectors of the population have access to opportunities that prepare them to become fully engaged in
the sciences and to lead the scientific enterprise. U.S. citizens and permanent residents belonging to
certain ethnic groups are significantly underrepresented in their participation in the scientific enterprise
(including basic biomedical sciences), technology, engineering and mathematics (STEM) as are
economically/socially disadvantaged and disabled people. By doing authentic research and presenting it
we expect students develop a strong self-efficacy and agency as scientists. We will accomplish this through
readings on bias and hegemony that serves to exclude UR students from science. The overarching goal
is to broaden diversity of those participating in basic biomedical research careers. To increase the pool of
high-achieving students, we propose to continue and enhance several levels of intervention, including
Summer Math and Language Arts for a one-month workshop, Science 100, and a new Freshmen seminar
series. Some of these high-achieving students will apply to the mentored research component of the U-
RISE program. The trainees will receive training in responsible conduct in research, molecular biology,
conduct authentic research, advisement, mentoring from PIs and research preceptors, attend U-RISE
seminar series, statistics and research rigor, opportunities to practice critical thinking skills, and
communication. This structured program will ultimately prepare them for graduate school and lead to the
Ph.D. or MD/Ph.D. Historically under represented students are Afro-Americans, Mexican-Americans and
other Latinos, Native Americans, Pacific Islanders, Filipinos and Southeast Asians. CSUN also has a large
population of disabled and Pell eligible students. The U-RISE Advisory Committee will select trainees from
these pools. The goal of this research component is to place 70% of students who complete the program
in Ph.D. or MD/Ph.D. programs. In the previous 15 years of MARC U*STAR, program (2004-19), student
persistence in Ph.D. or MD/Ph.D. programs is 88%. We expect similar outcomes from this new U-RISE
program.

Public health relevance
Narrative. The future of our nation requires a well-trained scientific workforce that is inclusive and as diverse as the populations that comprise the USA. Unfortunately, not all demographic groups have access to the opportunities that prepare them for careers in basic biomedical sciences e.g. U.S. citizens and permanent residents belonging to certain ethnic groups are especially underrepresented in their participation in science, technology, engineering, mathematics (STEM) and in basic biomedical research careers. The proposed holistic program is integrated and developmentally-appropriate, that will enhance trainees’ critical thinking, self- efficacy, research capacity, and communication skills so that at graduation, these undergraduates will have the skills and mental agility to gain entry into top-tier research programs, to further science, and to become independent inclusive scientists and leaders in the scientific enterprise.